BIOREMEDIATION OF POLLUTANTS

Our group is conducting research on the use of composting and bioaugmentation for the bioremediation of contaminated soils in Michigan. We used mass spectrometry this year to help us identify a group of pollutants in a contaminated soil from a Michigan Department of Environmental Quality orphan site located near Monroe, Michigan. Our GC analysis of samples from this site revealed a variety of known pollutants, however the identity of one group of chlorinated compounds was unknown. GC-MS was used to identify these pollutants which were the predominant man-made chemicals in the soil.